CHROMOSOMAL ABNORMALITIES THAT HIGHLIGHT REGIONS OF DIFFERENTIATED ACTIVITY

We are interested in the mechanism(s) of chromosomal rearrangements because they represent such profound examples of genomic instability. We also utilize the recognition of chromosomal rearrangements as useful tools in the diagnosis, staging, treatment planning, and risk assessment of individuals or populations predisposed to the development of cancer (see separate project). But the cloning and characterization of chromosomal abnormalities is also, for us, a starting point in the investigation of genes which play crucial roles in the growth and/or development of the cells in which the aberration occurs. That this be so is based on the concept that aberrations are more likely to occur in chromatin regions that are "open", active, and accessible. This premise has been the foundation of a successful program of gene identification and characterization within our laboratory. This strategy has led us to the discovery of four interesting and important human genes. Three of these genes are members of the basic domain-helix-loop-helix (BHLH) family of transcription factors, a family known to act in nodal points of tissue specific developmental processes. One of these genes, SCL, appears to play a role in early hematopoietic development, the other two are more likely to be active in early human nervous system development. We have also identified a gene, SIL, which may be the first known tissue specific topoisomerase, and which forms a fusion message with SCL subsequent to an interstitial deletion of chromosome 1 in approximately 20% of children with T-cell acute lymphoblastic leukemia.